AMP B/FLUCYTOSIN VS AMP B/FLUCONAZOLE IN ACUTE CRYPTOCOCCAL MENINGITIS

This study is designed to determine the relative antifungal activity of amphotericin B, with or without flucytosine, followed by triazole therapy as treatment for acute AIDS-associated cryptococcal meningitis.